CORTISOL FAST FEEDBACK AND CORTICOTROPIN RELEASING FACTOR (CRF)

The purpose of this study is to document fast feedback of rising plasma cortisol levels on the ACTH response to CRF, and to experimentally manipulate this effect by cortisol infusions.